BCM Oncology Scholars Training Program

DESCRIPTION (provided by applicant): Translational research training in oncology requires a mentoring program with components from multiple disciplines. In recent years, there has been a shortage of young investigators with both clinical and laboratory research expertise. In order to increase the pool of talented physician-scientists and Ph.D. scientists in translational cancer research we need to improve training opportunities. The BCM Oncology Scholars Training Program aims to address the needs of both M.D. (or M.D./Ph.D.) and Ph.D. trainees. The program is composed of five scientific research themes including: (1) Omics sciences (genomics, proteomics and metabolomics); (2) Cancer signaling pathways; (3) Stem cells and development; (4) Therapeutics and diagnostics; (5) Cancer epidemiology and prevention. From each class of Baylor hematology/oncology fellows, we will select a scholar and provide three years of research support and mentoring, starting in the second half of the fellowship and extending into the first eighteen months of a junior faculty position. To train Ph.D. the translational research in oncology, we will also select a Ph.D. postdoctoral scholar each year from the BCM postdoctoral pool via open competition and support her/his translational cancer research for three years. Each scholar trainee will receive a training program in oncological research including didactic courses, career development skills and mentored laboratory research. Each trainee will receive mentorship tailored to the specific interests of the trainees. Through co-mentorship for the M.D. and Ph.D. scholars between research mentors and clinical faculty, and a program-specific research seminar series, the proposed T32 will serve as a platform to develop translational cancer collaborative research for our trainees and to nurture their career development.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal aims to train young physicians and researchers so that they can conduct research to improve the diagnosis and treatment for cancer. The training program will equip young investigators with the state-of-the-art knowledge and skills in cancer research. This program will also foster career development of the trainees, and provide critical mentoring and support for the trainees to launch their careers in translational cancer research.